Targeting neurogenesis-inhibition coupling to improve memory in aging\Diversity Supplement

The hippocampus plays a critical role in the formation of episodic memories by generating distinct, conjunctive
representations of (spatial and social) experiences and transferring these representations to prefrontal cortical
sites for memory storage or consolidation. Age-related cognitive decline and mild-cognitive impairment (MCI)
are characterized by increased memory interference, decreased stability of memory representations and
inefficient memory consolidation. Evidence from humans, non-human primates and rodents demonstrate
reduced hippocampal neurogenesis, hippocampal hyperactivity and inflexible remapping during age- related
cognitive decline and MCI. Parvalbumin inhibitory interneurons (PV INs) play a pivotal role in memory
discrimination and consolidation by regulating neuronal excitability and synchronizing neuronal firing underlying
neuronal ensembles and sharp-wave ripples (SWRs). Thus, reduced PV IN recruitment in hippocampal CA2, a
hub for social memory processing, may contribute to age-associated social memory impairments. Here, we
propose a role for neurogenesis-inhibition coupling in the dentate gyrus-CA2 as a candidate circuit mechanism
by which adult-born neurons promote social memory consolidation in adulthood and aging. In response to the
FOA, we will develop and validate an in vivo gain-of-function platform for iterative testing of pro-cognitive
potential of novel candidate regulators of neurogenesis-inhibition coupling during aging. Towards this goal, we
will build on extensive preliminary and published data and integrate a genetic approach to enhance
neurogenesis, input-specific manipulation of PV INs, activity-dependent molecular profiling of PV INs, PV IN
targeted viral expression, optogenetics, ex vivo and in vivo local field potential recordings and an aging-
sensitive social memory behavioral paradigm. Together, these Aims will establish proof-of-concept for a novel
platform for targeting a neurogenesis-inhibition coupling mechanism to improve social memory in aging and
MCI.

Public health relevance
Our proposal exemplifies how identification of neural circuit mechanisms by which adult-born neurons contribute to memory may edify new strategies to improve social memory in aging and mild-cognitive impairment.